Administrative Core

Administrative Core
Director (P.l.): Jeffrey D. Laskin, Ph.D.
Deputy Director: Debra L. Laskin, Ph.D.
Center Administrator: Kristin Borbely
Business Manager: Linda Everett
Core Summary/Abstract
The Administrative Core will be responsible for day-to-day operations in the Center, promoting continuity and
scientific interactions between Center members at Rutgers, Lehigh and New York Medical College and
corporate partners (Target Health, MRIGlobal, Azevan, Janssen, Nevakar, Argentum, Allergan/Abbvie) that
facilitate research and the development of countermeasures against mustard vesicants; the Core will oversee
the management and activities of the Research and Development Projects, the Scientific Support Cores, and
the Research Education Core, and be responsible for establishing, refining and implementing Center goals.
The Administrative Core will oversee research project milestones and ensure that they are defined with
quantitative success criteria that facilitate go/no go decisions, and that they advance the overall goals of the
Center. The Core will ensure that project specific aims facilitate synergism across research cores, and that the
research is integrated into the objectives and milestones of the Center. The Administrative Core will oversee
the effective use of Scientific Support Core resources to further research and development activities. It will also
provide an effective planning and evaluation processes that assesses productivity of research projects and
allocation of resources. Additional activities of the Administrative Core include providing statistical support,
coordinating intellectual property, and patents and licensing, establishing goals and metrics, communicating
with institutional officials, and overseeing progression of candidate therapeutics. Through effective
management, the Administrative Core will ensure that activities and accomplishments of the Rutgers
CounterACT Center are greater than the sum of its parts.